TBI-induced exosome release accelerates Alzheimer's disease pathology

Alzheimer's disease (AD) is characterized by build-up of Aβ peptides forming amyloid plaques and hyper-
phosphorylation of tau protein forming neurofibrillary tangles, a two-fold protein aggregation process leading to
progressive neurodegeneration and cognitive decline. Epidemiological studies show that the risk of developing
AD is 4-fold higher in persons who have experienced head trauma or traumatic brain injury (TBI), which is
prevalent in Veterans returning from active combat. Reasons for this increased risk are unclear and no strategy
to prevent AD pathology exists. A critical barrier to progress is the lack of understanding of how amyloid and
tau are rendered neurotoxic, and how TBI may induce or accelerate this process. Our goal is to understand
and prevent amyloid and tau neurotoxicity and delay the onset and reduce neurodegeneration in AD,
particularly when induced or accelerated by TBI in Veterans. Our central hypothesis is that TBI-induced
shear force shakes and repeatedly bends cilia in astrocytes, which leads to calcium influx, reprogramming of
ceramide metabolism, and sustained secretion of ceramide-enriched exosomes termed “astrosomes”
(immediate effect). Aβ42 and tau associate with ceramide and turn astrosomes into neurotoxic betasomes,
even years after TBI (delayed effect). Betasomes also contain prostate apoptosis response 4 (PAR-4), a
protein sensitizing neurons to ceramide-induced apoptosis. Betasomes are transported to mitochondria, where
they enhance Aβ42 and tau-mediated mitochondrial dysfunction and neurotoxicity. Consistent with our
hypothesis, betasomes are detectable in serum from AD patients and 5xFAD mice and induce mitochondrial
damage, caspase activation, and tau aggregation in N2a cells and primary cultured neurons. Our hypothesis
predicts that astrosome secretion, association with Aβ42 and tau, and neurotoxicity are prevented by blocking
TBI-induced calcium influx and ceramide generation. Our expected outcomes include 1) determining
enzymes in upregulation of ceramide and specific calcium channels that are activated by shear force; 2)
defining a ceramide composition in astrosomes that induces interaction with Aβ42, tau aggregation, and
mito/neurotoxicity; 3) identifying ceramide-modulating drugs and calcium channel blockers that prevent
astrosome secretion, betasome formation, mitochondrial dysfunction, and tau aggregation and neurotoxicity;
and 4) quantifying astrosomes and betasomes in serum that indicate severity of TBI-induced AD (TBI-AD) and
success of therapeutic treatment. The impact of this project on protection of Veterans and public health will
include knowledge needed for the development of new treatment strategies that could delay and/or prevent the
onset of progressive neurodegeneration in AD, in particular when induced by mild TBI in Veterans.

Public health relevance
Traumatic brain injury (TBI) resulting from combat is a prevalent head injury among Veterans. TBI can increase the risk of developing Alzheimer's disease (AD) by 4-fold. AD is characterized by build-up of amyloid peptides forming plaques and hyper-phosphorylation of tau protein forming neurofibrillary tangles, a two-fold protein aggregation process leading to neurodegeneration and cognitive decline. It is not known how TBI increases the risk of developing AD and how to prevent TBI-induced AD. Our research showed that even mild TBI elicits shear forces in the brain that make particular cells secrete vesicles called exosomes. These TBI-induced exosomes bind to amyloid peptide and tau protein and enhance their neurotoxicity. Our goal is to interrupt TBI- induced exosome secretion to prevent or delay the onset of AD in Veterans.